Modeling Microbiome Peptides Using Metaproteomics for the Prediction of Harmful Algal Blooms

Project Abstract
Harmful algal blooms (HABs) are a reoccurring toxic event threatening public health through the contamination
of water quality worldwide. Various toxic phytoplankton species regularly undergo bloom events in both coastal
and inland water bodies, wreaking havoc for water treatment facilities, fishing, and recreational industries,
amassing ~$11 billion annually in healthcare costs related to human exposure. As changes in climate and
agriculture continue to alter water chemistry, bloom events have been observed to occur more frequently, last
longer, and release a wider range of toxic chemicals. Currently, there exists no method for predicting bloom
onset, leaving the public vulnerable to a spectrum of potentially avoidable harmful toxins.
A long history of shared ecosystems and co-occurring evolution has established a close relationship between
HAB-forming phytoplankton and their microbiome. Bacteria have been shown to respond to the photosynthetic
circadian rhythm of the algae, mimicking circadian patterns in the expression of metabolically necessary proteins.
A significant change in the ecosystem is likely to cause reactionary changes in patterns of protein expression,
detectable as either individual peptides or peptide-groups sharing similar taxonomic origin or functional category.
If the established circadian rhythmicity of a peptide or group of peptides is lost >24 hours prior to HAB initiation,
it could be used as an indicator to predict impending bloom toxicity. I hypothesize that tracking the quantified
expressed peptides of the HAB-associated microbiome will allow me to detect rhythmicity and the loss of
rhythmicity of those peptides; these peptides, or groups of peptides, can serve as biomarkers to be
developed as bioassays or probes for forecasting HABs to better warn the public.
For this project, I will be collecting time-dependent water samples of the microbiome surrounding the known
HAB-forming phytoplankton Pseudo-nitzschia biannually in Puget Sound, WA. My experimental design includes
working with Washington’s Sound Toxins Program to conduct high-resolution sampling of the phytoplankton
microbiome every 4 hours beginning 2 weeks prior to a predicted bloom event and sampling until HAB-toxins
peak. I will then analyze the microbiome samples using quantitative data-independent acquisition mass
spectrometry methods to establish time-dependent peptide abundances. These peptides will be grouped and
annotated into all potential taxonomic and functional groups using MetaGOmics and time-course data will be
analyzed using Rhythmicity Analysis Incorporating Non-parametric methods. This will allow me to detect
rhythmicity from individual peptides (AIM 1) and peptides grouped by taxa or function (AIM 2) prior to the bloom
event. Peptides or peptide groups exhibiting significant changes in or loss of rhythmicity prior to bloom onset
represent potential biomarkers for the future development of a rapid molecular peptide-based assay or probe for
predicting HAB events. This project uses advances in metaproteomic methods to prevent harmful human
exposure to HAB toxins by predicting bloom onset using microbiome biomarker peptide groups.

Public health relevance
Project Narrative Harmful algal blooms (HABs) are a regular, detrimental environmental occurrence that seasonally plagues coastal and inland waters worldwide, resulting in a variety of health issues ranging from dermatitis and asthma to neurological damage or even death, all of which could be prevented if a reliable method for early HAB detection existed. In this project, I propose using an innovative metaproteomics analysis to quantify and track individual HAB-associated microbiome peptides through circadian expression with the goal of identifying when and which peptides lose circadian-rhythmicity to determine candidate biomarkers for predicting HAB bloom. Through further investigations using high-resolution taxonomic and functional groupings of those peptides, I will develop a HAB forecasting tool with relevancy in exposure science, biomarker development, and microbiome understanding, that can serve to warn the public of oncoming HABs, ultimately bridging the fields of biomedical and environmental research.